AI-informed Signaling Factor Design for in vitro Rejuvenating Mesenchymal Stromal Cells

ABSTRACT
While mesenchymal stromal cells (MSCs) hold great promise for treating many challenging diseases, a
major barrier to clinically meaningful MSC therapies is the inability to consistently produce potent MSCs. In vitro
cultured MSCs often rapidly enter senescence and lose their potency, driven largely by misregulated metabolic
signaling in culture. To address this, many signaling pathways (e.g., FGF, ATM, SRT, mTOR, EGF, DDR2) have
been identified as regulators of senescence-related processes. Building upon these discoveries, this R35 MIRA
project aims to develop an innovative approach to delay MSC senescence by collectively adjusting these
pathways.
In this administrative supplement proposal, we aim to address an unexpected technical hurdle
encountered in the parent award and introduce an innovative research aim by acquiring the Nikon NSPARC
confocal imaging module. Over the past two years, our efforts to resolve recurring issues with our current
confocal system have been unsuccessful, leading us to rely on a suboptimal epifluorescent microscope for AI
training data. Following extensive research, we have identified the Nikon NSPARC module as the optimal
replacement, offering high-resolution and high-throughput imaging essential for detailed observation of
subcellular structures like mitochondria, endoplasmic reticulum, and histone marks. Its low phototoxicity also
makes it suitable for live cell imaging, allowing us to explore dynamic cellular information and enhance our AI
model’s prediction of cell senescence states. Overall, this supplementary application, seeking to acquire a Nikon
Spatial Array Confocal Module, aims to overcome an unexpected technical obstacle critical to fulfilling the
objectives of the parent award while also augmenting our imaging capacity to explore novel hypotheses in
deciphering metabolism-based senescence pathways and rejuvenation mechanisms.

Public health relevance
PROJECT NARRATIVE Mesenchymal stromal cells (MSCs) are promising for treating many challenging diseases, but they are difficult to produce due to rapid aging and loss of therapeutic functions during expansion. This proposal aims to develop an AI-based method to design drugs that delay MSC aging by controlling their biochemical signaling. Upon completion, this project will enable reproducible production of highly potent MSCs and advance our fundamental understanding of aging signaling in these cells.